Spindle Assembly Checkpoint Silencing

ABSTRACT
The Spindle Assembly Checkpoint (SAC) is a signaling pathway responsible for the fidelity of chromosome
segregation. Disruption of this process leads to catastrophic cellular consequences, such as aneuploidy and
cancer. The primary effector of the SAC is the inhibitory complex known as Mitotic Checkpoint Complex
(MCC). MCC is responsible for binding and inhibiting the 1.2 MDa ubiquitin ligase Anaphase-Promoting
Complex/Cyclosome (APC). Once all of the sister chromatids achieve proper bipolar orientation, MCC is
dismantled. This restores APC activity to trigger the ubiquitin-mediated proteasomal destruction of key mitotic
regulators, e.g. Cyclin B and Securin, permitting mitotic exit. The mechanisms of release and disassembly of
APC-bound MCC (BUBR1, MAD2, BUB3, and CDC20- an APC coactivator) by a triad of large multiprotein
enzymes remain poorly understood. I aim to dissect this process using an innovative technological approach
involving enzyme kinetics, chemical crosslinking, protein engineering, electron microscopy, NMR,
crystallography, and cell-based assays. Information generated from the proposed research will have a long-
lasting impact on the cell cycle field and may enable the development of novel cancer therapeutics.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Aneuploidy, a hallmark of human cancers, is prevented by a surveillance system known as the Spindle Assembly Checkpoint (SAC). Timely disassembly of the SAC effector, Mitotic Checkpoint Complex (MCC), by several multiprotein complexes is required to ensure accurate chromosome segregation. Comprehensive examination of the structural and enzymatic mechanisms of these molecular machines may enable the design of therapeutics for many cancers.